Leveraging technology to enhance eye disease detection: a pragmatic randomized trial

Abstract Text
In the United States, seven million people live with visual impairment and one million live with
blindness; glaucoma is a leading cause of this visual disability. Though glaucoma is treatable, only
half of people with the disease are ever diagnosed. Federally qualified health centers (FQHCs)
provide medical care for people who are publicly insured but only 3% of patients at FQHCs receive
eye care. FQHCs provide care for people who are more likely to: 1) have glaucoma and 2) receive
inadequate treatment for glaucoma. There is a critical need to rigorously test the effectiveness and
cost effectiveness of innovative, holistic strategies to screen for glaucoma and other eye disease in
the national network of FQHCs. The scientific premise of this proposal is based on the efficacy of
our technology-based protocols that identified glaucoma and other eye disease at higher rates than
national averages at an FQHC when run by our academic medical center. In this proposal, eye
doctors at the FQHC – instead of university physicians – will use technology-based protocols to
review digital, objective ophthalmic data captured by FQHC ophthalmic technicians to triage
patients to appropriate inperson care, a 30-minute detailed visit or a 10-minute wellness visit, to
increase clinical efficiency. The ophthalmic technicians act as health care navigators to help
people access affordable glasses from on-line retailers and recommended medical treatment. Our
objective is to test the effectiveness of this comprehensive technology-based approach to
glaucoma and eye disease screening compared to usual care (a comprehensive eye exam) and
evaluate implementation and costs. We will conduct a Type 1 effectivenessimplementation hybrid
randomized pragmatic clinical trial to test whether technology-based screening is more effective
than usual care in 1) identifying glaucoma/suspected glaucoma, visually significant cataract, and
diabetic retinopathy, and 2) improving vision-related quality-of-life six weeks after participation. We
will explore the impact of our technology-based screening program on treatment of refractive error,
satisfaction with glasses and care, and completion of recommended follow-up care. We will assess
the sensitivity and specificity of protocol-based and standard optometric exam to gold standard
glaucoma specialist evaluation to identify areas for improvement. (Aim 1). We will use
implementation science strategies to identify best strategies to implement whichever glaucoma
and eye disease screening protocol is most effective at the local FQHC after the trial. We will create
a toolkit of how to implement evidence-based eye care for other FQHCs (Aim 2). Due to the need for
advanced technology-based equipment, we will assess costs and model costeffectiveness to
compare the societal value of technology-based glaucoma screening versus usual care (Aim 3).
This work will inform our long-term goal to leverage the existing network of FQHCs to provide high
quality eye disease screening and care.

Public health relevance
Public Health Relevance Statement PROJECT NARRATIVE To prevent blindness from glaucoma, we need to: 1) screen populations with high disease prevalence and 2) assist with appropriate eye care for those who screen positive. Nationwide, Federally Qualified Health Centers (FQHCs) provide care to populations who have a higher prevalence of glaucoma than national averages. Testing whether technology-based glaucoma and eye disease screening is more effective and cost effective compared to usual care in detecting three leading causes of blindness (glaucoma, diabetic retinopathy, and cataract) at an FQHC will create best practices to scale quality eye care at FQHCs nationwide.